TRIAL OF 120,240,360 MG OF IDEBENONE IN PATIENTS WITH ALZHEIMER'S DISEASE

Twelve month study to evaluate the safety and efficacy of this antioxidant in three doses for treatment of Alzheimer's Disease.